Advancing the implementation of variant-level functional data into clinical databases and clinical practice

SUMMARY
One of the major challenges limiting the potential of genomic medicine to revolutionize clinical care is the
current lack of knowledge about the function of most human genetic variants. Consequently, the majority of
clinically encountered genetic variants are classiﬁed as variants of uncertain signiﬁcance (VUS), which cannot
be used for clinical decision making given their unknown relationship to disease. The VUS problem is
particularly acute for individuals from populations historically excluded from research, compounding existing
healthcare inequities when implementing genomic medicine.
Variant-level functional data has the potential to overcome many of these challenges by providing pathogenicity
information for variants from diverse populations. For example, we and others have demonstrated that
multiplexed assays of variant effect (MAVEs) can resolve a large fraction of VUS in clinically important genes
(e.g., 49% of BRCA1 VUS, 69% of TP53 VUS, and 93% of DDX3X VUS), and several U.S. and international
consortia are currently using MAVEs to produce functional data for all possible coding and non-coding variants
associated with all genes that have been linked to human disease. Given the potential of functional information
to augment the implementation of genomic medicine, clinical guidelines have recently been updated to
recommend the use of variant-level functional data when interpreting variant pathogenicity. However, despite
the potential clinical utility of large-scale functional datasets, how best to implement them such that clinicians
can appropriately incorporate variant functional data into clinical practice remains unknown.
In this proposal we aim to address this unmet need in genomic medicine using the following approach:
● First, we will generate a framework for standardizing and disseminating curated large-scale functional
data into clinician-facing resources, and implement this framework into ClinVar (Aim 1)
● Second, we will perform a proof-of-concept integration of variant level functional data in ClinVar into two
large clinical practices to evaluate the clinical uptake and impact of variant-level functional data (Aim 2).
● Finally, we will build and disseminate resources for training clinicians on best practices for integrating
functional data into clinical practice (Aim 3).
Overall, this proposal has the potential to significantly advance the implementation of genomic data into clinical
practice by enabling clinicians to appropriately leverage emerging variant-level functional data to resolve VUS,
thereby making genomic medicine more equitable and impactful.

Public health relevance
PROJECT NARRATIVE Large-scale variant-level functional data can substantially reduce the clinical burden of variants of uncertain significance, but no infrastructure exists to capture and present this data to clinicians in a manner that can be incorporated into standard clinical variant interpretation workflows. We propose to leverage our leadership in both large-scale functional assay technology development and clinical genetics to address this critical challenge by building and testing the infrastructure and knowledgebase that will empower clinicians to integrate variant-level functional data into clinical practice.